Elucidation of the alcohol effect on tumor suppressor genes

Project Summary
Chronic and excessive alcohol consumption is known to cause multiple diseases including alcohol-
related liver disease and liver cancer. It is estimated that approximately 25% of cirrhosis deaths and
~20% of hepatocellular carcinoma (HCC)-related deaths in the world are associated with alcohol.
However, the pathogenesis of the alcohol-related HCC remains incompletely understood. Tumor
suppressor genes are known to have protective functions against cancer development. But very
little is known which tumor suppressor genes are crucial in the alcohol-related HCC. In this
application, we will use both candidate and systemic approaches to identify and characterize
key tumor suppressor genes and their roles in the alcohol-related HCC development. It is
expected that the findings from this innovative research will provide insights into risk
assessment, HCC prevention, and therapeutic development.

Public health relevance
Project Narrative The proposed research in this application is relevant to public health because better understanding of the tumor suppressor genes will help prevent and treat alcohol-related liver cancer. Thus, this project is highly relevant to the part of NIH’s mission that pertains to pursuing fundamental knowledge that will help extend healthy life and reduce the burdens of illness.